The histone deacetylase SIRT6 modulates Transcriptional pausing

ABSTRACT
The eukaryotic genome is packaged into chromatin, which limits the accessibility of RNA polymerase
during transcription. Recent finding in metazoan systems have revealed that much of the transcription
regulation occurs downstream of recruitment of the polymerase, through modulation of pausing and the
efficiency of early elongation (Adelman and Lis, 2012). Although we have learned some of the molecular
players that modulate escape from promoter proximal pausing, whether chromatin accessibility and
which chromatin modifiers modulate this process, remains to be fully understood. Remarkably, we have
recently identified the histone deacetylase SIRT6 as a central regulator of embryonic differentiation and
metabolism, modulating expression of key developmental and metabolic genes to adapt against nutrient
stress (Mostoslavsky et al., 2006; Zhong et al., 2010; Etchegaray et al., 2015); furthermore, SIRT6 acts
as a tumor suppressor, inhibiting cancer metabolism amd Myc-dependent transcription (Sebastian et al.,
2012; Kugel et al., 2015; Kugel et al., 2016). These studies indicate that fine-tuning of gene expression
by SIRT6 is key to maintain cellular homeostasis. In this proposal, we will test the innovative idea that
SIRT6 acts downstream of recruitment of the polymerase to modulate promoter proximal pausing, a
novel, previously unidentified mechanism of regulation for an histone deacetylase. Specifically, we will 1)
Determine, at the molecular level, the function of SIRT6 in transcriptional elongation 2) Decipher,
biochemically, whether SIRT6 controls elongation using defined, fully reconstituted in-vitro systems and
biochemical assays to test transcriptional elongation in chromatinized templates. 3) Determine the
physiological relevance for SIRT6 roles in transcriptional elongation during early embryonic development.
Overall, our results should provide new insights into the molecular mechanisms of transcriptional
regulation, in particular those related to early development and adaptive responses to metabolic cues, a
knowledge that may inform treatment against developmental diseases, metabolic diseases and cancer.

Public health relevance
Project Narrative Proper regulation of gene expression represents one of the most important characteristics of appropriate cell function; each one of our cells, despite carrying all the genetic information in its DNA, expresses only a subset of specific genes in order to maintain its cell fate, differentiation stage, and growing characteristics. At the molecular level, we are still trying to understand how expression of specific genes is fine-tuned and specifically coordinated; our laboratory has identified a protein, called SIRT6, that functions as a modulator of chromatin, a highly dynamic structure that compacts DNA, in turn acting as a key regulator of embryonic development, metabolism and cancer. In this proposal, we will use biochemical and biological approaches, as well as genetically engineered cells and induced pluripotent human cells from patients with mutations in SIRT6 to test the hypothesis that SIRT6 regulates activation of metabolic and developmental genes through a novel, previously unrecognized mechanism of action.